The PET Radiotracer Translation and Resource Center (PET-RTRC) Training & Dissemination

Technology Training and Dissemination Project Summary
In this renewal application, the Technology Training and Dissemination Core (TTD) will build upon its success
during the current funding cycle by incorporating strategies we have learned through its establishment, expanding
its scientific innovations, in responding to the challenges imposed by the COVID-19 pandemic, and that honor
requests by Center partners or other members of the scientific community. In the process, the TTD will continue to
offer a robust training program to facilitate the use of radiotracers developed by the Center and inform the scientific
community about its capabilities and accomplishments to promote and enable broader use of Center products. To
achieve these objectives the TTD will address the following Specific Aims:
Training:
Aim 1: The TTD will now offer workshops and seminars in the field of PET addressing key topics of interest to the
scientific community in hybrid onsite/remote mode. It will partner in these efforts with other P41 centers with similar
and complementary missions. Additional outreach initiatives will include interactions with internal WU training
grants/programs and traditionally underserved universities.
Aim 2: In addition to on-site individualized training, the TTD will offer a virtual option using “how to” videos in which
trainees can interact with a proctor to ask questions about specific methods being shown.
Dissemination
Aim 1: The TTD will offer new innovations to our Service Projects such as the capability to perform human research
with Center radiotracers and offering expertise to sites developing radiotracers with assistance in pre-clinical
imaging facility operation and/or in focused areas of exploratory investigational new drug applications.
Aim 2: With support of the MIR Marketing team, the TTD will continue to fortify the PET-RTRC web site by
providing interested parties detailed information on the Center, mechanisms for registration for Center events, as
well as links to other related NIH funded P41 Centers and to the NIBIB's NCBIB program web page.
Aim 3: The TTD will continue to pursue numerous strategies to increase scientific outreach and visibility for the Center,
including continued publication of our center newsletter, interactions at scientific meetings of imagers and other
potential users, organize workshops as described above, and vigorous use of social media.
By pursuing these strategies will ensure the PET-RTRC can meet its training and dissemination goals.

Public health relevance
Technology Training and Dissemination Core Project Narrative Per the instructions in PAR-20-169, please see Overall Project Narrative.